Network Properties of Circadian Clock Modulation and Entrainment

Abstract
Circadian clocks orchestrate endogenous daily rhythms in physiology, metabolism, and behavior that
must be adjusted (i.e., entrained) to environmental cycles to maintain properly timed outputs. Post-
industrial environments have significantly reduced the reliability of the time cues that the circadian system
relies upon for entrainment and this has had widespread and negative consequences for human health.
Understanding the network properties of circadian timekeeping in the brain and the ways in which time
cues impinge upon it is required if we are to address the adverse effects of circadian misalignment and
dysfunction. The complexity of the brain’s clock center is a significant barrier to our understanding of the
daily adjustment of the circadian system. Work in relatively “simple” clock neuron networks can therefore
enrich and inform our understanding of circadian timekeeping and entrainment in the mammalian brain.
The goal of this competing renewal application is to continue a productive and impactful research program
on the network properties of circadian timekeeping and entrainment in Drosophila melanogaster, which,
despite its relative simplicity, shares molecular, anatomical, and physiological features that are
remarkably similar to those of mammalian clock networks. Within the fly’s clock neuron network, we will
determine how endogenous circadian timekeeping is supported by the network structure of the of the
brain’s clock center and how specific neural pathways and neurotransmitters mediate entrainment to
environmental cycles. The goals of our three specific aims are to elucidate: 1) the nature and timekeeping
functions of the synaptic and modulatory connections of the circadian clock neuron network, 2.) how the
CCNN integrates light input to entrain circadian rhythms, and 3) how neurons that do not themselves
express molecular clocks participate in the clock neuron network to support endogenous timekeeping.
The unifying goal of this research program is to advance our understanding of circadian timekeeping and
entrainment in the brain. The results of this work will inform future interventions for the alleviation of the
adverse health effects of circadian dysfunction in post-industrial environments.

Public health relevance
Narrative The proper alignment of internal circadian clocks with the 24-hour rhythm of the environment is critical for human well-being. A central goal of chronobiology is to understand how the brain’s circadian clock center is organized and how it is modulated by environmental time-cues. Here we propose a continuation of a productive and impactful research program using Drosophila melanogaster to understand the mechanisms that circadian neural networks employ to create an endogenous sense of time and how these networks integrate environmental time-cues to ensure the proper coordination of the internal circadian system with external time.